Targeting the Epidermal Growth Factor Receptor (EGFR) to Revert Trastuzumab Deruxtecan Resistance in HER2-low Colorectal Cancer.

PROJECT SUMMARY/ABSTRACT
Therapeutic exploitation of the HER2 (human epidermal growth factor receptor 2) receptor tyrosine kinase
(RTK) has led to remarkable improvements in clinical outcomes for many cancer types. HER2 amplification
occurs in ~4% of metastatic colorectal cancers (mCRCs), in which it acts as an oncogenic driver and can be
targeted with the antibody-drug conjugate (ADC) trastuzumab deruxtecan (T-DXd). However, in the larger
group of patients (~10–50%) with HER2 expression but lacking frank amplification (i.e., HER2-low), targeting
HER2 with T-DXd has been ineffective, with a response rate of 0% in mCRC. This is in contrast with breast
and gastric cancers, in which T-DXd is active against HER2-low tumors. We have investigated this insensitivity
of CRC and have published preliminary evidence that the antitumor activity of T-DXd is attenuated by the
frequent overexpression of epidermal growth factor receptor (EGFR) in the large bowel. In the presence of high
levels of EGFR, we find that instead of forming HER2-HER2 homodimers, HER2 abundantly heterodimerizes
with EGFR and is thereby less effective at internalizing T-DXd. We further demonstrated that combined
treatment of the anti-EGFR antibody cetuximab with T-DXd restores the ability of HER2 to form homodimers
and internalize drug in several HER2-expressing CRC patient-derived xenograft (PDX) models. This drug
combination leads to durable and more profound tumor growth inhibition than T-DXd alone in multiple PDX
models of HER2-expressing CRC. However, some of the molecular details on which cancers have the best
response to this combination need to be elucidated. In this proposal, we will conduct a biomarker-intensive,
investigator-initiated phase 2 trial of T-DXd + cetuximab in patients with chemorefractory HER2-low mCRC to
determine both the safety of this drug combination, as well as the molecular context in which it proves most
efficacious. The trial will begin with a safety lead-in of 6–18 patients followed by an expansion phase to enroll a
total of 27 patients to a single cohort following a Simon minimax two-stage design. Our central hypothesis is
that the addition of cetuximab will enhance the efficacy of T-DXd in patients with HER2-low mCRC. To facilitate
a mechanistic understanding of therapeutic response, we propose a co-clinical trial to generate novel PDX
models of HER2-low CRC to study in vivo mechanisms of response and resistance to T-DXd + cetuximab. We
hypothesize that expression of other RTKs, receptor dimerization dynamics, and downstream RAS/MAPK
signaling will affect internalization of T-DXd and tumor response to T-DXd + cetuximab. We will evaluate these
factors at baseline and at resistance in patient samples and throughout treatment in PDX models to define
mediators of response and resistance. Resistance alterations identified in clinical samples will be functionally
validated in cell lines and PDXs. We believe that T-DXd + cetuximab has the potential to become the first
targeted therapy for patients with HER2-low mCRC, improving outcomes for a large portion of patients with
CRC and refining our understanding and application of HER2-targeted ADCs in CRC.

Public health relevance
PROJECT NARRATIVE We propose a mechanism-based combination treatment that has great potential to improve outcomes for the large portion of colorectal cancer patients whose tumors have low human epidermal growth factor receptor 2 (HER2) expression, a group without targeted therapy options. The antibody-drug conjugate trastuzumab deruxtecan (T-DXd) has transformed the care of breast cancer patients with low HER2 expression but is not active against HER2-low metastatic colorectal cancer. Based on our preclinical findings that the presence of epidermal growth factor receptor (EGFR) in the colorectum limits the activity of T-DXd against HER2-low colorectal cancers, we will investigate the safety, efficacy, and biological effects of the novel combination of cetuximab (an anti-EGFR antibody) with T-DXd to overcome this resistance in a clinical trial and the associated correlative studies using tissue and blood samples and patient-derived xenograft models.